Uncovering Cross-Disease Platelet Transcriptomic Signatures to Advance Precision Medicine

PROJECT SUMMARY
Cardiovascular, immune-mediated, cancer, and hematologic diseases, including myeloproliferative neoplasms
(MPNs), represent major public health burdens. Despite extensive research on these conditions, gaps remain in
our understanding of the role of platelets across these diverse disease processes. Platelets contribute not only
to hemostasis but also play integral roles in inflammation, immune response, and disease progression. Their
molecular functions in these processes, however, are incompletely understood, which limits the development of
targeted, cross-disease diagnostic and therapeutic strategies. Identifying common molecular pathways in
platelets across these disease categories is crucial for informing biomarker discovery and universal therapeutic
targets, ultimately advancing precision medicine for NHLBI-relevant diseases.
This proposal aims to bridge critical knowledge gaps by examining platelet transcriptomes across cardiovascular,
immune-mediated, cancer, and hematologic diseases, identifying shared and unique molecular pathways.
Utilizing curated platelet RNA-sequencing datasets from over 2,000 ancestrally diverse individuals with
varied phenotypes, we will leverage advanced machine learning and bioinformatics tools to elucidate these
cross-disease signatures.
Aim 1 will employ methods such as Identifiable Deep Generative Models (DGM), Non-negative Matrix
Factorization (NMF), and Principal Component Analysis (PCA) to compare platelet transcriptomic profiles across
cardiovascular, immune-mediated, cancer, and hematologic conditions. This analysis aims to reveal common
and unique pathways, which may serve as shared biomarkers or therapeutic targets. Aim 2 will focus on
constructing a comprehensive, functionally annotated multi-disease platelet transcriptomic atlas. This resource
will analyze gene expression patterns, isoforms, alternative splicing, and allele-specific expression variations,
providing valuable insights into the conserved and disease-specific functions of platelets.
Completion of these aims will yield a novel, cross-disease platelet transcriptomic atlas, offering an invaluable
resource for biomarker discovery and therapeutic interventions in NHLBI-relevant diseases. This research not
only addresses critical gaps in our understanding of platelet biology but also aims to enhance clinical applications
in precision medicine, advancing patient care for diverse populations affected by these high-impact diseases.

Public health relevance
PROJECT NARRATIVE This project aims to uncover shared and unique molecular pathways in platelet transcriptomes across cardiovascular, immune-mediated, cancer, and hematologic diseases. By leveraging advanced machine learning tools and a curated dataset of over 2,000 ancestrally diverse individuals, we will build a cross-disease platelet transcriptomic atlas to identify conserved pathways and biomarkers. This research will inform targeted diagnostic and therapeutic strategies, enhancing precision medicine for diverse populations affected by these high-impact NHLBI-relevant diseases.